TDA LFFM Administration Component

Administrative Project Abstract TSL administrative staff will work in support of an integrated food safety system. Internal projects involving microbiology, special projects, and chemistry will be supported.

Public health relevance
Administrative Proposal Narrative Technical Services Laboratory (TSL) administrative staff will support internal projects. Staff will be attending annual MFRPS and AFRPS Face to Face Meetings as well as relevant training. TSL's USALIMS subscription will be supported through this project.